METABOLIC EFFECTS OF THEOPHYLLINE IN NEWBORN INFANTS

This study will determine the effects of theophylline on energy metabolism in newborn infants with apnea. Specifically, these studies will test the hypotheses that theophylline: 1) impedes growth by increasing energy expenditure; 2) increases rate of lipid oxidation; 3) decreases body fat stores. Stable isotope tracer techniques will be the primary methods used.